Target validation of CD206 activators

During this period, the collaborative team has worked on obtaining a cryo-EM structure of CD206 bound to small molecule ligands. Additionally, the team has identified novel CD206 activators through molecular modeling and medicinal chemistry efforts, which have been extensively characterized in a variety of in vitro and in vivo functional assays. Small molecule effects on macrophage phenotypes and anti-tumor activity are being characterized, towards development of a novel immunotherapy. The team nominated a lead molecule based on preclinical testing results.